Proximity Based Therapeutics

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Proximity Based Therapeutics, organized by
Drs. Ryan Potts and Michelle Arkin. The conference will be held in Copper, Colorado from January 21-24, 2024.
Drug discovery is undergoing a revolution that moves away from occupancy-driven pharmacology to proximity-
based therapeutics that take advantage of event driven pharmacology. Induced proximity medicines or “multi-
specifics” mobilize a cell’s natural biological mechanisms to operate on disease-causing proteins by bringing
together these proteins with cellular effectors capable of regulating target activity or abundance. Proximity based
therapeutics have the potential to unlock new target space and make significant inroads to drug the
“undruggable” genome. This conference will focus on understanding the opportunities and challenges in this
exciting new area. The program includes topics such as: 1) Controlling Post-Translational Modifications by
Induced Proximity; 2) Emerging Proximity Biology for Target Degradation; 3) Stabilizing Protein-Protein
Interactions with Molecular Glues; and 4) Predicting and Discovering Ternary Complexes. The conference
program is designed to bring together interdisciplinary groups of scientists, including biologists and chemists,
from both academic and industry to explore the latest findings in this field and accelerate its growth. Finally, this
conference will be held jointly with Targeted Protein Degradation. This pairing will lead to synergistic interactions
between these two communities and will enhance momentum in basic and translation research, while providing
networking and career development opportunities at shared meals and poster sessions.

Public health relevance
PROJECT NARRATIVE Drug discovery is undergoing a revolution that is now using molecules to induce “closeness” of cellular molecules as a new approach to developing therapeutics. “Proximity-based therapeutics” have the potential to regulate biological targets in a new way that will allow the development of drugs for diseases thought to have previously been “undruggable”. This conference program will bring together interdisciplinary groups of scientists, including biologists and chemists, from both academic and industry to explore the latest findings in this field and accelerate its growth.